IMAGING OF DEFECTS IN OFFSPRING OF MUTAGENIZED MICE

MRI microscopy provides an efficient method for the detection of anatomical defects in fixed embryos, as demonstrated by preliminary studies on mouse hearts.